Muller glial cell pathophysiology during glaucoma onset

PROJECT SUMMARY
The goal of this proposal is to understand how glial cell pathophysiology contributes to disease progression in
glaucoma, a neurodegenerative eye disease characterized by dysfunction and death of retinal ganglion cells
(RGCs), the output neurons of the retina. Elevated intraocular pressure (IOP) is the most common risk factor for
glaucoma, yet the mechanisms linking high IOP and RGC loss remain poorly understood. Here, we focus on an
important but previously unexamined aspect of disease progression: how early structural remodeling of Müller
glial cells contributes to degeneration of RGCs. In glaucoma, as in other retinal diseases, Müller cells undergo a
variety of molecular and morphological changes referred to as reactive gliosis. However, little is known regarding
how Müller cells respond to ocular hypertension early in disease or how gliosis leads to RGC degeneration. We
will use a combination of optical imaging, transgenic mice, viral techniques, and patch-clamp electrophysiology
in an ex vivo eyecup preparation to fill these gaps in our knowledge. Aberrant Ca2+ signaling during disease
onset may be an important upstream event that occurs prior to overt signs of Müller cell gliosis. In Aim 1A, we
will test the hypothesis, suggested by our preliminary findings, that elevated pressure induces excessive Ca2+
signaling in Müller cell peri-synaptic processes within the inner plexiform layer (IPL) of the retina. We will use
two-photon (2P) microscopy to compare Ca2+ signals in Müller glia in eyes with normal pressure vs. eyes in
which IOP has been chronically elevated in a microbead occlusion model of glaucoma. In Aim 1B, we will directly
test whether changes in Ca2+ signaling can drive morphological changes in Müller cells by selectively
manipulating Müller cell intracellular [Ca2+]. Experiments in Aim 2A will use the microbead occlusion model and
2P imaging of fluorescently labeled Müller glia and RGCs to investigate whether ocular hypertension alters the
physical relationship between Müller glial fine processes and RGC dendrites. In our preliminary work examining
the morphology of Müller cells in tissue from eyes with chronically elevated IOP, we found that Müller cell
processes retract within specific sublayers of the IPL. We will test the hypothesis, suggested by these preliminary
findings, that Müller cell processes selectively withdraw from certain RGC subtypes soon after onset of ocular
hypertension. An important function of Müller cell peri-synaptic processes is to regulate extracellular glutamate
near synapses. Withdrawal of Müller glia could contribute importantly to disease progression by promoting RGC
death via excitotoxic damage. Experiments in Aim 2B will examine this possibility by using two-photon Ca2+
imaging to test the hypothesis that elevated IOP increases light-evoked N-methyl-D-aspartate-type glutamate
receptor activity in the dendrites of specific RGC subtypes. In both Aims, we will focus specifically on early-stage
disease by conducting experiments within the first 1-2 weeks after IOP elevation. By identifying
pathophysiological changes in Müller cells that occur early in disease progression, this work will help reveal
novel ways to diagnose and treat glaucoma before RGC degeneration leads to irreversible vision loss.

Public health relevance
PROJECT NARRATIVE Pathological changes to glial cell structure are a hallmark of many neurodegenerative eye diseases. Our goal is to understand how such changes contribute to disease progression in glaucoma. By advancing knowledge of glial cell dysfunction during disease onset, our work will identify new ways to diagnose and treat glaucoma before irreversible vision loss occurs.